Building Accessible and Inclusive Paths for Students in Biomedical Informatics and Data Science- Sup 3

This Section is Not Required for An Administrative Supplement

Public health relevance
Deaf and Hard of Hearing DHH persons are highly underrepresented in the research community, making up less than 1% of STEM Doctorate recipients. To address this disparity, the University of Pittsburgh (Pitt) and Gallaudet University (GU) will partner to create the Accessible and Inclusive Biomedical Informatics and Data Science (AIBIDS) program which is unique for its focus on empowering both DHH students and persons from other underrepresented groups in the sciences to lead biomedical informatics and data science research. The program will increase the inclusion and accessibility of biomedical informatics and data science research through authentic, accessible, and inclusive mentored research internships with experienced faculty and near- peer mentors to a highly diverse group of undergraduate and Masters level students.